METTL3-NUP93 interaction facilitates the nuclear export of m6A-modified mRNAs

PROJECT ABSTRACT
The nucleus-cytoplasm shuttling of messenger RNAs (mRNAs) is a key determinant in the spatiotemporal
articulation of gene expression. This process is finely tuned by multiple factors, one of which is the addition of a
methyl moiety onto the adenosine base at the nitrogen-6 position (m6A). Emerging evidence suggests that
m6A enhances the nuclear export of decorated mRNAs. Current theories explaining m6A-assisted mRNA
export focus on the crosstalk between the protein enzymes involved in m6A modification and the typical RNA-
binding adaptor proteins that hand the mRNA cargoes over to the classical export receptors. In this study, we
have found a noncanonical transport axis for m6A-marked mRNAs.
Our preliminary data have shown that METTL3, an integral subunit of the m6A methyltransferase complex,
directly interacts with NUP93, a component of the nuclear pore complex (NPC). RNA-binding capacity of
METTL3 helps link the m6A-modified mRNAs to NUP93 on the nuclear envelope, which accelerates the
passage of mRNA cargoes through the NPCs with the assistance of the principal export factor NXF1-NXT1.
Integrative analysis of the m6A profile and fractionation transcriptome has identified a large group of m6A-
harboring mRNAs whose nuclear export is dependent on the METTL3-NUP93 complex. Interestingly, these
mRNAs are distinguished from other transcripts, as they tend to have longer 3' untranslated regions (3'-UTR),
which is associated with more m6A sites and stronger methylation intensities. In addition, Gene Ontology
analysis has revealed important functions of these transcripts in cellular physiology. In this regard, we found
that the genetic mutations on NUP93, which have been reported to cause steroid-resistant nephrotic syndrome
(SRNS) in humans, disrupts its interaction with METTL3, implying a potential association between
dysregulation of METTL3-NUP93 axis and development of certain pathological conditions. Being guided by
these preliminary data, we have developed biological systems to monitor the m6A status of test mRNA species
and will employ cutting-edge technologies, such as single-point edge-excitation subdiffraction microscopy and
epitranscriptome-editing tools, to define the role of METTL3-NUP93 axis in the nuclear export of m6A-
conjugated mRNAs. Our Specific Aims are: (1). To examine how the METTL3-NUP93 interaction facilitates the
nuclear export of m6A-marked mRNAs; (2). To determine which transcripts are specifically regulated by the
METTL3-NUP93 axis; (3). To elucidate why this new mRNA transport pathway is biologically important.
Our proposed research will impact upon the fields of RNA biology and epigenetics. Findings from this
study will help delineate a novel mechanism of m6A-assisted mRNA export and offer new therapeutic targets
for certain human diseases, such as kidney abnormalities that are caused by NUP93 mutations.

Public health relevance
PROJECT NARRATIVE Methylation of messenger RNAs (mRNAs) at the nitrogen-6 position of adenosine (m6A) has been suggested to enhance mRNA nuclear export through the interactions between m6A regulators and classical adaptor proteins of mRNA transport pathways. We have found that m6A methyltransferase METTL3 associates with the nuclear pore complex (NPC) via directly binding to a structural NPC component called NUP93, which assists in loading m6A-decorated mRNAs to the nuclear membrane and expedites their translocation through the NPC by the export receptor NXF1-NXT1. We aim to elaborate on each crucial step of this new mRNA transport axis and define the full repertoire of the target mRNAs. We will also investigate the basis of pathogenesis that stems from a defect in the METTL3-NUP93 interaction. As such, our proposed research will furnish novel insights into the function of the epitranscriptomic mark m6A in nuclear mRNA export and define its health relevance.